Metabolism during the Progression of Photoreceptor Degeneration

Project Summary/Abstract
Retinitis pigmentosa (RP) is an inherited, early-onset, and irreversible form of vision loss. RP can result from
mutations in over 100 unique genes. The burden of developing individualized treatments for each mutation is
high, so strategies that improve photoreceptor health regardless of mutation would be benefit patients.
RP perturbs retina energy metabolism, and disrupted energy metabolism can cause degeneration. Metabolic
reprogramming may prevent photoreceptor loss. Reprogramming efforts should be aimed at correcting
changes that occur with RP, yet it is unclear which changes to correct. In RP there are disruptions in
glucose transport, aerobic glycolysis and the normal expression of TCA cycle and pentose phosphate pathway
(PPP) genes. Due to critical gaps in these studies, the nature and timing of these changes is unclear. The lack
of comprehensive detail on how RP alters metabolic flux hampers efforts to protect photoreceptors.
The aims of this application are aimed at understanding changes to metabolism in RP. Specifically, in aim 1 I
will determine how the rate of metabolism changes with disease stage. I will infuse 13C-labeled glucose or
lactate through catheters to probe flux of carbons through metabolic pathways in the retina and RPE-choroid. I
will quantify 13C accumulation in metabolites of glycolysis, the TCA cycle, the PPP, gluconeogenesis, and
glycogen. Metabolites that fuel these pathways must first be transported from circulation, through the retinal
pigment epithelium (RPE), and to the retina. In Aim 2 I will determine metabolites that increase O2
consumption by ex vivo RPE-choroid, and which of these best labels intermediates in the RPE-choroid in vivo.
This proposal also seeks support for my career development. My development goals include presenting my
work at conferences and leveraging these presentations to form a scientific network. I will also take scientific
and non-scientific courses to improve my ability to perform surgeries and mentor young scientists. These
opportunities will prepare me for a position as an independent investigator, where I can continue to fulfill the
aims of this proposal and further develop my research program.

Public health relevance
Narrative Retinitis pigmentosa (RP) results in untreatable vision loss and may be caused by deficits in energy metabolism. Efforts to compensate for these deficits have been hampered by a lack of comprehensive data on metabolic changes associated with degeneration. The proposed studies seek to understand these changes and help to guide the development of therapeutics that bypass metabolic deficits in RP.